A Mechanoimmunological Basis for Metastatic Site Preference

Summary
Antitumor immunosurveillance by cytotoxic lymphocytes is generally conceived as a biochemical process in
which tumor specific markers are recognized by activating receptors on the lymphocyte surface. We have found,
however, that cytotoxic T cells and natural killer cells also respond to the mechanical properties of cancer cells,
preferentially destroying targets that are physically stiffer. This mechanical form of immunosurveillance, which
we call mechanosurveillance, appears to be particularly relevant during metastasis, when cancer cells remodel
their cytoskeleton to invade new organs. In this proposal, we will investigate the interplay between
mechanosurveillance and the physical properties of the metastatic microenvironment. Cellular mechanics are
modulated continuously by cell-extrinsic biophysical signals. A particularly important manifestation of this
crosstalk, called mechanoreciprocity, induces cells in stiffer environments become stiffer themselves, and those
in softer locales to become softer. Whether environmentally-induced stiffening might sensitize cancer cells to
mechanosurveillance in vivo, however, has not been explored. This an interesting question because metastatic
microenvironments vary widely in their physical properties, ranging from very rigid (e.g. bone) to very soft (e.g.
lung). Enhanced mechanosurveillance in rigid microenvironments would establish a regime in which cytotoxic
lymphocytes control the spectrum of metastatic site preference by disproportionately suppressing outgrowth in
organs like the bone. Using a mouse model of metastasis, we have found that cancer cells colonizing the bone
are significantly stiffer than cancer cells colonizing the lung, and that the in vivo expansion of bone metastasis is
exquisitely sensitive to cytotoxic lymphocytes. Building on these preliminary observations, we propose that
microenvironmental stiffness dictates the efficacy of mechanosurveillance and that this relationship shapes both
metastatic site preference and the power of anti-tumor immunotherapy. We will investigate this hypothesis in
three Specific Aims. Aim 1 will examine how distinct metastatic microenvironments affect cancer cell
biomechanics and immune vulnerability in mice and humans. Aim 2 will determine if environmental stiffness can,
as an independent variable, control the efficiency of mechanosurveillance. Finally, Aim 3 will apply state-of-the-
art rigidity dependent cell sorting technology to identify novel mechanoregulators of metastasis in vivo. Our
proposed studies are organized around the conceptually innovative idea that crosstalk between environmental
mechanics and cellular cytotoxicity determines where metastases grow. In addition, we will employ highly
innovative technologies, including suspended microchannel resonator (SMR) devices that rapidly measure cell
deformability and sort cells based on stiffness. The successful completion of our Specific Aims could identify
biomarkers for guiding antitumor immunotherapy and aid development of novel strategies for treating metastatic
growth in specific target organs. As such, this work is highly relevant to the NIH mission in that it will contribute
to the advancement of knowledge that could improve human health.

Public health relevance
Project Narrative Metastases form in a wide range of target organs that vary not only in their chemical composition but also in their mechanical rigidity. We have found that patrolling immune cells preferentially engage and destroy stiffer cancer cells. Our proposed studies will investigate if and how the rigidity of the metastatic microenvironment influences the stiffness dependent killing of cancer cells and, by extension, whether the interplay between tissue mechanics and immune function effectively dictates where metastases grow.